Development and pilot testing of a mobile health application to improve HIV prevention and substance use treatment service access among women involved in the carceral system

Project Summary
Women involved with the carceral system are more at risk of HIV infection, substance use disorders, and
overdose than their community-based counterparts. Pre-exposure prophylaxis (PrEP) has emerged as a
powerful HIV-prevention tool and in combination with Medication for Opioid Use Disorder (MOUD) could
significantly impact HIV and overdose risk. Patient navigation holds strong potential to address multifactorial
and complex barriers to PrEP and substance use treatment linkage and uptake for women involved in the
carceral system. In tandem with patient navigation, eHealth has the potential to improve healthcare
engagement for this group of women. As a multidisciplinary team with expertise in HIV-prevention
implementation science research, technology enhanced, gender-responsive, and behavioral health focused
(substance use, mental health and HIV prevention) interventions, and intervention development for individuals
involved in the carceral system, we propose to examine the potential impact of using a technology-based
adjunct to an existing navigation program to improve linkage to PrEP and MOUD for women leaving carceral
settings in Philadelphia (PA). Intervention development and study design will be guided by our team’s pilot and
on-going research, and the EPIS Implementation Framework. Study aims are to: 1) Assess women involved in
the carceral systems’ perceptions of PrEP and MOUD and potential barriers to initiation and adherence; 2)
Develop the PA-Links web-based app and assess usability and acceptability; and 3) Pilot the intervention to
assess for promise of efficacy in engaging women involved in the carceral systems in PrEP and MOUD by
integrating PA-Links into existing patient navigation. A survey of women involved in the carceral system and
perceptual mapping analyses will be used in Aim 1 to guide proto-type app development and user testing in Aim
2. In Aim 3, we will examine the primary outcome of PrEP and MOUD service linkage and secondary outcomes
such as PrEP and MOUD prescription/initiation, PrEP and MOUD adherence/persistence, perceptions and
knowledge, and acceptability of the intervention. A Community Advisory Board will inform all aspects of the
proposed study. This pilot study will significantly contribute to the field of HIV and substance abuse treatment by
examining the potential impact of using technology based, tailored, gender-responsive interventions in adjunct
with existing navigation in an urban, community-based health center. Study results will provide crucial
information for a subsequent R01 proposal to rigorously evaluate an urgently needed HIV prevention
intervention developed specifically to meet the unique cultural and social needs of high-risk women.

Public health relevance
Project Narrative Women involved in the carceral system are at an increased risk of opioid use disorder, overdose and HIV- acquisition. Given the disproportionate number of racial/ethnic minority women, carceral settings provide an opportunity to reduce racial/ethnic disparities in HIV and opioid use disorder treatment engagement by linking these women with innovative biomedical HIV prevention strategies (e.g., pre-exposure prophylaxis; PrEP) and medications for opioid use disorder (MOUD) treatment services. Providing linkage to these services using technology that provides women peer and healthcare provider support could be novel, so we propose the development and pilot testing of the PA-Links web-based app to enhance communication in an existing post- release navigation model embedded in a community-based health services organization in Pennsylvania.